Ionic liquid-based nanoemulsion containing combination antiretroviral drugs for the oral and transdermal treatment of HIV infection

PROJECT SUMMARY
Two-drug regimen (2-DR) containing potent second-generation integrase inhibitor (INI) and non-nucleoside
reverse transcriptase inhibitor (NNRTI) are currently available as oral formulation (dolutegravir-rilpivirine) and
long-acting injectable nanosuspension (cabotegravir-rilpivirine) for HIV prophylaxis and therapy. Oral 2-DR tablet
(Juluca; dolutegravir-rilpivirine) is equally effective but with significantly lower adverse effects compared to the
three-drug regimen based on 2 NRTIs. However, dolutegravir (DTG) and rilpivirine (RPV) both have pH
dependent solubility, low oral bioavailability and long-term use of INI can lead to metabolic diseases including
diabetes. Given the need for lifelong administration of these drugs, strategies that can improve the oral
bioavailability of DTG and RPV are highly desirable for optimal drug utilization and to achieve a reduction in
therapeutic dose and dose-related side effects. While the intramuscular long-acting cabotegravir-RPV
nanosuspension is highly effective in the long-term management of HIV infections, there is a strong need to
develop a non-invasive, strategy that can allow for self-administration and long-term HIV therapy. The non-
invasive transdermal route is yet to be explored for the delivery of 2-DR containing INI and NNRTI. Ionic liquids
(ILs) are low-melting organic salts with a melting point < 100°C and pharmaceutically acceptable fatty cations
and/or anions can be used to develop amphiphilic ILs with excellent drug solubilization capacity.
Pharmaceutically acceptable cations and fatty anions can be assembled into amphiphilic ILs with excellent
biocompatibility and drug solubilization capabilities. We hypothesize that carnitine, a generally regarded as safe
(GRAS) cation and fatty anionic permeation enhancers with GRAS status can be assembled to develop
amphiphilic ILs with excellent solubilization capacity for hydrophobic drugs such as DTG and RPV and that
subsequent incorporation of these ILs into oral lipid-based formulations (LBFs) such as self-nanoemulsifying
systems (SNES) and transdermal LBFs such as nanoemulsion-based gel will improve oral and transdermal
delivery of DTG-RPV combination. Our preliminary data show that a co-processed mixture of DTG and RPV has
very high solubility (RPV: ~ 166 mg/g and DTG: 334 mg/ml) in amphiphilic carnitine IL (carnitine salcaprozate)
and carnitine salcaprozate containing DTG-RPV mixture showed significantly higher in vitro permeability through
skin mimicking Strat-M membrane compared to DTG-RPV suspension. Aim 1 will focus on the development,
characterization, and in vitro evaluation of nanoemulsion of carnitine ILs containing DTG-RPV combination
suitable for oral and transdermal delivery. Aim 2 will focus on the pharmacokinetic evaluation of oral and
transdermal lipid nanoformulations of carnitine IL containing DTG-RPV combination in healthy mice to establish
the proof of concept. The successful completion of this proposal will lead to the development of pharmaceutically
viable formulations containing INI based 2-DR to achieve effective long-term management of HIV infection in a
non-invasive manner and this strategy can be expanded to other antiretroviral drug combinations.

Public health relevance
PROJECT NARRATIVE The patients infected with HIV require lifelong treatment with antiretroviral drugs. Integrase inhibitor (INI) based two-drug regimen such as dolutegravir-rilpivirine is effective for HIV therapy whereas cabotegravir-rilpivirine intramuscular long-acting nanosuspension is available for HIV prevention and therapy. However, both dolutegravir and rilpivirine have low and fatty meal dependent oral bioavailability and injectable cabotegravir- rilpivirine nanosuspension is invasive and cannot be self-administered. This project will develop novel strategies to improve oral and transdermal delivery of dolutegravir-rilpivirine combination for non-invasive and effective management of HIV infections and for HIV prophylaxis.